Role of Prefrontal Cortex in Real World Navigation in Young and Old Primates

Project Summary
This project focuses on the development of noninvasive therapeutic interventions in humans to improve
spatial cognition due to declines seen during healthy and pathological aging. Both normal and
pathophysiological processes that occur in aging result in difficulties navigating. These challenges can
be profoundly debilitating. A central capacity in navigation is the ability to plan routes to goals. While
the brain circuits for navigation are increasingly well-characterized, the nature of neural representations
of goals for goal-directed navigation remain less so. We aim to describe neural representations for goal
locations for navigation. In order to fully describe these representations and how they change in aging,
both young and old nonhuman primates will run mazes in virtual reality while wireless neural recordings
are performed in the prefrontal cortex. An important tool to explore computations for goal-directed
navigation in humans is the use of virtual reality. But there are important differences between virtual
reality and real life navigation, and the generalization of findings in virtual reality to the real world must
be explored. To aid in understanding how such findings can be extended to the real world, we aim to
directly compare neural activity in both contexts by building real world mazes that match virtual ones.
Monkeys will learn to navigate a maze for rewards in virtual reality and then assessed in real world
analogues. This novel experimental design will allow the direct comparison of neuronal activity and
learning in virtual mazes to activity and behavior in real world mazes. Finally, in order to spur the
development of therapies to address the scourge of age-related declines in spatial cognition, we will
utilize noninvasive repetitive transcranial magnetic stimulation, already approved to treat major
depression disorder, to stimulate activity in the prefrontal cortex in both young and old monkeys. We
will examine how this intervention changes the neural activity and the behavior as monkeys run mazes.
We anticipate that we will be able to rescue observed deficits in navigation in older monkeys using such
intervention and hence potentially advance a new path of treatment for declines in spatial cognition in
the elderly.

Public health relevance
Project Narrative Getting lost in familiar environments is a hallmark of aging and results in stress and depression in the elderly. Despite these challenges for navigation, our understanding of how the brain represents goals during navigation and the development of interventions to address these challenges is still minimal. In this research, we will describe how the prefrontal cortex of young and old primates represents goals for navigation and investigate the use of brain stimulation to try to improve their capacity to navigate in the real world.